MECHANISMS UNDERLYING ABNORMAL AMBULATORY BLOOD PRESSURE PATTERNS

We plan to 1) identify subjects at risk for the development of HTN, 2) determine the influence of risk, status (HR vs NR) or ABP patterns on a normal Na+ diet and determine the influence of risk status on 24-hour hormonal patterns (PRA, PAC<ACTH) on a normal Na+ diet, 3) determine the influence of risk status on pattern of renal hemodynamics and proximal tubular reabsorption and compare the groups with regard to the relationship among the hormonal activity.